COMPUTATIONAL FACILITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Resource's computational facility provides the necessary computational resources utilized by Resource scientists. The facility offers Resource researchers and collaborators tools such as large local disk storage for their files and research data, various computational machines and clusters for simulation and data analysis, and advanced visualization workstations and projection facilities featuring 3D stereoscopic visualization and imaging. This facility saw many improvements over the past year (http://www.ks.uiuc.edu/Development/Computers/).